Tracking the flow of malaria parasites and drug resistance within the DRC and across its borders

ABSTRACT
Malaria​ ​remains​ ​endemic​ ​in​ ​sub-Saharan​ ​Africa​ ​in​ ​large​ ​part​ ​due​ ​to​ ​continued​ ​evolution​ ​and​ ​spread​ ​of​ ​drug
resistance​ ​which​ ​undermines​ ​ongoing​ ​large-scale​ ​control​ ​and​ ​elimination​ ​efforts.​ ​We​ ​will​ ​leverage
high-throughput​ ​genotyping​ ​of​ ​parasites​ ​using​ ​a​ ​state-of-the-art​ ​panel​ ​of​ ​molecular​ ​inversion​ ​probes​ ​(MIPs)​ ​for
targeted​ ​sequencing​ ​of​ ​thousands​ ​of​ ​resistance​ ​and​ ​neutral​ ​loci​ ​across​ ​thousands​ ​of​ ​infections​ ​covering​ ​the
entire​ ​Democratic​ ​Republic​ ​of​ ​Congo​ ​(DRC)​ ​and​ ​select​ ​areas​ ​in​ ​bordering​ ​countries.​ ​This​ ​will​ ​provide​ ​us​ ​a​ ​map
with​ ​an​ ​unprecedented​ ​scale​ ​and​ ​resolution​ ​to​ ​define​ ​the​ ​evolution​ ​and​ ​spread​ ​of​ ​antimalarial​ ​resistance
mutations.​ ​In​ ​this​ ​project,​ ​we​ ​will​ ​first​ ​develop​ ​our​ ​genotyping​ ​panel​ ​which​ ​should​ ​provide​ ​a​ ​high-resolution​ ​tool
for​ ​studying​ ​all​ ​known​ ​drug​ ​resistance​ ​loci​ ​and​ ​general​ ​parasite​ ​population​ ​structure​ ​in​ ​this​ ​and​ ​other​ ​settings.
Applying​ ​this​ ​to​ ​well​ ​annotated​ ​samples​ ​from​ ​across​ ​the​ ​DRC​ ​and​ ​bordering​ ​countries,​ ​we​ ​will​ ​define​ ​the
prevalence​ ​of​ ​drug​ ​resistance​ ​mutations​ ​and​ ​define​ ​them​ ​based​ ​on​ ​their​ ​genetic​ ​haplotypes​ ​which​ ​act​ ​as​ ​a
unique​ ​fingerprints.​ ​We​ ​will​ ​then​ ​map​ ​these​ ​drug​ ​resistance​ ​haplotypes​ ​and​ ​study​ ​their​ ​spread​ ​and​ ​spatial
associations​ ​and​ ​further​ ​examine​ ​their​ ​epidemiologic​ ​associations​ ​and​ ​interactions.​ ​Onto​ ​this​ ​detailed​ ​spatial
map,​ ​we​ ​will​ ​​ ​examine​ ​specific​ ​locales​ ​of​ ​interest​ ​for​ ​temporal​ ​changes.​ ​​ ​These​ ​focal​ ​regions​ ​in​ ​the​ ​DRC
represent​ ​diverse​ ​ecologic​ ​and​ ​demographic​ ​features​ ​that​ ​likely​ ​impact​ ​resistance​ ​spread​ ​and​ ​evolution
including​ ​areas​ ​with​ ​minimal​ ​health​ ​care​ ​infrastructure​ ​and​ ​ongoing​ ​regions​ ​of​ ​conflict.​ ​Our​ ​final​ ​work​ ​will​ ​be​ ​to
apply​ ​more​ ​sophisticated​ ​models​ ​to​ ​the​ ​rich​ ​sequence​ ​data​ ​in​ ​order​ ​to​ ​estimate​ ​the​ ​flow​ ​of​ ​parasites​ ​and
resistance​ ​mutations​ ​within​ ​and​ ​between​ ​the​ ​DRC.​ ​This​ ​includes​ ​the​ ​development​ ​of​ ​new​ ​​ ​population​ ​structure
models​ ​(MALECOT)​ ​incorporating​ ​parasite​ ​infections​ ​that​ ​have​ ​multiple​ ​strains​ ​allowing​ ​for​ ​a​ ​better
understanding​ ​of​ ​the​ ​full​ ​dataset​ ​as​ ​in​ ​polyclonal​ ​infections​ ​are​ ​often​ ​the​ ​majority​ ​in​ ​endemic​ ​African​ ​countries.
This​ ​model​ ​should​ ​be​ ​broadly​ ​applicable​ ​to​ ​other​ ​studies​ ​of​ ​malaria​ ​or​ ​infections​ ​with​ ​mixed​ ​strains.​ ​We​ ​will
also​ ​leverage​ ​​ ​spatially​ ​explicit​ ​models​ ​to​ ​define​ ​general​ ​parasite​ ​flow​ ​in​ ​both​ ​relative​ ​and​ ​absolute​ ​terms
comparing​ ​and​ ​contrasting​ ​to​ ​the​ ​flow​ ​of​ ​resistant​ ​parasites.​ ​This​ ​work​ ​will​ ​provide​ ​the​ ​patterns​ ​of​ ​general​ ​gene
flow​ ​and​ ​barriers​ ​on​ ​the​ ​spread​ ​of​ ​specific​ ​drug​ ​resistance​ ​alleles​ ​and​ ​haplotypes.​ ​In​ ​summary,​ ​not​ ​only​ ​will
this​ ​project​ ​enhance​ ​our​ ​understanding​ ​of​ ​malaria​ ​landscape​ ​genetics​ ​and​ ​the​ ​evolution​ ​and​ ​spread​ ​of
antimalarial​ ​resistance,​ ​it​ ​will​ ​provide​ ​tools​ ​and​ ​analysis​ ​framework​ ​for​ ​improving​ ​public​ ​health​ ​interventions
that​ ​will​ ​directly​ ​inform​ ​the​ ​DRC​ ​National​ ​Malaria​ ​Control​ ​Program.

Public health relevance
PROJECT NARRATIVE Falciparum malaria remains a major global public health problem and the continued evolution and spread of drug resistance impedes control efforts in endemic countries such as the Democratic Republic of Congo. To better understand the evolution and spread of drug resistance this project will genotype thousands of malaria infections from across the entire country to define all known resistance genes and determine barriers and corridors of gene flow that can be targeted in public health interventions.